Copper Homeostasis and Liver Function

PROJECT SUMMARY
Wilson disease (WD) is a potentially fatal metabolic disorder caused by genetic mutations in the copper (Cu)
transporter ATP7B and Cu accumulation in tissues. Despite significant progress in identification of disease-
causing mutations, WD remains challenging to diagnose and treat. Using new experimental models and
protocols, this project will develop a comprehensive model of WD pathogenesis and identify new targets for
treatment. Specific Aim 1 will generate an integrated picture of multi-cellular Atp7b-/- liver response to Cu
overload in WD using single cell sequencing data, immunostaining, and qPCR studies. The role of
metallothioneins in disease onset and progression will be examined, and sex-specific differences in metabolic
status of the WD liver will be characterized. The results will be used to identify unique characteristics of hepatic
WD when compared to phenotypically overlapping liver diseases. In Specific Aim 2, the new mouse strain,
Atp7bMac, with Atp7b deleted in cells of myeloid origin, will be characterized and further employed to
determine the role of Atp7b in functional maturation of neutrophils. The functional consequences of Atp7b
loss in myeloid cells will be determined following LPS injection and evaluation of immune response. Specific
Aim 3 will elucidate the liver-gut interaction in WD. By using in situ secretory protein labeling via ER-anchored
TurboID, we will compare liver secretomes of control, Atp7bMac mice and mice with a targeted deletion of
Atp7b in hepatocytes (Atp7bHep mice) to determine how liver signaling is altered by Cu misbalance in the gut
and in NPLC.

Public health relevance
PROJECT NARATIVE This project will determine how different cell types in the liver, intestine, and bone marrow respond to Atp7b inactivation and how they work together to produce the Wilson disease phenotype. The results of this project will help to better understand the pathogenesis of Wilson disease and identify new approaches to treatment.